Autophagy regulates β-hydroxybutyrate synthesis to prevent hypertension-associated premature vascular aging

PROJECT SUMMARY Hypertension is a condition of premature vascular aging, relative to actual chronological age. In fact, many factors that contribute to the deterioration of vascular function as we age are accelerated and exacerbated in hypertension. Nonetheless, our understanding of the mechanisms that cause arteries to prematurely age, thus increasing the cardiovascular risk for hypertensive patients, is yet to be determined. It is well established that the upregulation/reconstitution of autophagy ameliorates the aged phenotype, especially in the vasculature. Nonetheless, the precise mechanisms by which autophagy exerts anti-vascular aging effects, remain to be elucidated. Therefore, the long-term objective of this project is to uncover novel mechanisms by which autophagy ameliorates premature vascular aging associated with hypertension. Evolutionarily, autophagy serves to mobilize macro- and micronutrients in times of starvation and stress. As a result, autophagy has also been recognized as a mediator of hepatic lipid metabolism, which could then liberate substrates for ketogenesis. In the current proposal, we have revealed for the first time, that autophagy induces the synthesis of liver-derived ketone body, β-hydroxybutyrate (βOHB). Furthermore, we have observed that βOHB has profound anti-hypertensive effects, including potent vasodilation of isolated resistance arteries via the G protein-coupled receptor Gpr109a and potassium channels. Therefore, we hypothesize that upregulation of autophagy in liver, stimulates the production of βOHB, which induces vasodilation, and decreases phenotypes of premature vascular aging associated with hypertension. We will test this hypothesis by executing the following specific aims: 1) autophagy in the liver liberates lipid substrates for βOHB synthesis, 2) βOHB prevents vascular aging phenotypes by stimulating vasodilation via endothelial Gpr109a, as well as direct activation of potassium channels, and 3) decreased autophagic activity in hypertension reduces βOHB synthesis, contributing to high blood pressure and premature vascular aging. To execute these aims, we will investigate normotensive and genetically hypertensive rats in vivo, analyze isolated arteries from mice genetically deficient in Gpr109a ex vivo, and culture primary and immortalized hepatocytes in vitro. Collectively, this application proposes a novel, physiologic mechanism by which autophagy in the liver prevents premature vascular aging and also proposes a pathogenic consequence of decreased autophagic activity in hypertension. As vascular age is a new clinically used index for cardiovascular disease risk, understanding these mechanisms may assist in the development of new therapies to to reverse or prevent vascular damage associated with hypertension. Given that hypertension is a major public health burden in the United States, our proposal is very much in accordance with the mission of the National Institutes of Health.

Public health relevance
PROJECT NARRATIVE Hypertension is a condition of premature vascular aging, where the normal decline in vascular function as we age is accelerated and exacerbated. It is well established that upregulation of autophagy can ameliorate this “aged” phenotype; however, underlying mechanisms are yet to be determined. Given that autophagy also serves to mobilize macro- and micronutrients in times of stress, we hypothesize that upregulation of autophagy in the liver, stimulates the production of ketone body, β-hydroxybutyrate, which induces vasodilation, and decreases phenotypes of premature vascular aging associated with hypertension.